Dietary Interventions to Limit Heterotopic Ossification after Musculoskeletal Injury

Project Summary
Heterotopic ossification (HO) is a debilitating condition characterized by aberrant bone formation in soft tissues
following trauma or surgery, often leading to chronic pain, severe functional impairment, and reduced quality of
life. Notably, obesity increases the risk of developing HO, complicating recovery outcomes. Current treatment
options for HO are limited or invasive, underscoring the urgent need for innovative, non-invasive strategies to
prevent HO onset and progression. Recent studies suggest that dietary interventions, specifically calorie
restriction (CR) and intermittent fasting (IF), may hold therapeutic potential by modulating inflammation and
promoting tissue regeneration in other disease contexts. However, no dietary interventions currently exist to
prevent or reverse HO. This proposal aims to investigate dietary therapies, specifically CR and IF, as potential
interventions to target the key inflammatory and cellular pathways central to HO. The central hypothesis guiding
this research is that dietary modifications regulate HO formation and progression through CCL2-mediated
monocyte recruitment, with the timing of these modifications being crucial to their therapeutic efficacy. Aim 1 will
define the optimal therapeutic window for CR and IF, examining pre-injury and post-injury regimens to establish
the timing and duration of the diet that maximally suppresses HO formation in clinically relevant mouse models
of trauma and surgery. High resolution micro-computed tomography (µCT), histology, and functional
assessments will be used to evaluate treatment efficacy. Aim 2 will delineate the mechanistic effects of CR and
high-fat diet on mesenchymal progenitor cell (MPC)-monocyte interactions, focusing on the CCL2-CCR2
signaling axis. Lineage specific and global gene deletion mice with impaired CCL2-CCR2 signaling will be used
to investigate how dietary modifications impact monocyte recruitment, inflammation, and HO progression.
Advanced molecular techniques, including single-cell RNA sequencing (scRNA-seq), spatial transcriptomics,
and multiplexed ion beam imaging (MIBI), will be employed to evaluate how dietary interventions affect
inflammatory signaling and immune cell dynamics in HO. This research addresses a critical public health
challenge by aiming to develop novel, non-invasive dietary strategies that could prevent HO and transform
recovery and long-term outcomes for high-risk patients, particularly those with obesity. The applicant will conduct
this work under the mentorship of clinician scientist Dr. Benjamin Levi at UT Southwestern Medical Center, who
is a previous F32 recipient and who has mentored several F32 awardees who now run independent laboratories.
The training plan that includes advanced coursework and hands-on experience in scRNA-seq and spatial
transcriptomics, high-resolution imaging, immunology, bioinformatics, and metabolomic techniques, preparing
the applicant for a career as a physician-scientist specializing in tissue regeneration and wound healing.

Public health relevance
Project Narrative Heterotopic ossification (HO) is a painful, debilitating condition in which bone forms in soft tissue following trauma or surgery, severely impacting mobility and quality of life. This project aims to improve HO treatment by leveraging targeted dietary interventions—calorie restriction and intermittent fasting—to modulate key inflammatory pathways and cellular responses critical to aberrant bone formation. By identifying the optimal timing and mechanisms for these interventions, this research has the potential to establish safe, accessible dietary therapies for HO prevention, offering a non-invasive alternative that significantly improves recovery and long-term outcomes.